Bioinformatics Core

PROJECT SUMMARY
The overall goal of the Bioinformatics Core is to use advanced bioinformatics tools for identification and improved
understanding of the innate and adaptive immune response in influenza infection and vaccination and compare
with other diseases. The Bioinformatics Core will utilize existing informatics platforms, and adapt them as
needed, to achieve these goals. The goals of the Bioinformatics Core will (1) provide robust bioinformatics
methods to analyze the data generated by Projects 1, 2 and 3, and (2) analyze data from public repositories
including the NIAID-funded ImmPort and the NCBI Gene Expression Omnibus for the Projects for hypothesis
testing.
The Bioinformatics Core will directly work with all Projects to address their need for robust bioinformatics
techniques. The Bioinformatics Core will integrate the immune profiling data generated by all Projects with those
available from public repositories, to enable multi-cohort integrated analysis. The Bioinformatics Core will work
closely with the Human Immune Monitoring Center (HIMC) for this purpose. This will enable participating Projects
to maximally utilize the genomic, immune monitoring and clinical phenotypic data sets to determine functional
dependencies among the measured elements and to direct further biological validation of these putative
dependencies.